Biological functions of Interleukin - 26

Project Summary/Abstract:
In this proposal, we will define the functions of an understudied cytokine interleukin-26 (IL-26) at the mucosal
barrier using human and zebrafish models. Cytokines have pleiotropic functions for both the adaptive and
innate arms of the immune system to promote antimicrobial immunity, regulate inflammation, and maintain
tissue homeostasis. IL-26, produced by Th17 cells, is associated with inflammatory diseases in humans, such
as rheumatoid arthritis, ulcerative colitis, and psoriasis. The underlying role of IL-26 in these inflammatory
diseases is not well understood. Since mice do not encode the IL26 gene, studies that address the biology of
IL-26 have been lacking. Our understanding of IL-26 biology is primarily restricted to the effect IL-26 has on
epithelial cells, due to apparent tissue and cellular restriction of the IL-26 receptor. Moreover, as IL-26 is
absent in mice and other rodents, it has posed a significant barrier in understanding its biological functions. As
such, studies of IL-26 biology have been limited to in vitro cell culture models. However, we have identified a
homolog of human IL-26 in zebrafish that is characterized by a highly conserved IL-10 family signature motif
and has similar synteny as in humans. There is extensive sequence and functional conservation between
human and zebrafish genomes, including genes involved in innate and adaptive immunity. To this end, we will
(i) define the transcription and signaling networks induced by IL-26 in human keratinocytes and (ii) define the
role of IL-26 in antimicrobial responses at mucosal surfaces in zebrafish. The proposed experiments will
provide unprecedented insight into the biological function of IL-26 in inflammation and antimicrobial immunity,
with important implications for the role of IL-26 in initiation and progression of inflammatory disease.

Public health relevance
Project Narrative In this proposal, we will define the functions of an understudied cytokine interleukin (IL-26) at the mucosal barrier using human and zebrafish models. These data will lay the foundation to understand the contribution of IL-26 to antimicrobial immunity and the initiation and progression of inflammatory diseases.